CYTOLOGICAL DIAGNOSIS OF LYMPHOMAS BY IMMUNOCYTOCHEMISTRY

The cytological diagnosis of malignant lymphoma can be extremely difficult because the cytological features of the malignant cells in small cell and mixed small and large cell lymphomas may be indistinguishable from those of reactive lymphoid cells. We have examined the usefulness of the avidin biotin immunoperoxidase technique and a battery of antibodies to T and B cell markers to the diagnosis of lymphoma in cytological specimens. We conclude that immunocytochemistry is very useful in the cytological diagnosis of non-Hodgkin's lymphoma. Futher, it is possible to diagnose the vast majority of lymphomas using only the immunoglobulin light chain markers kappa and gamma and the T-cell markers Leu-1, Leu-2, and Leu-3.